IMMUNE MECHANISMS OF PROTECTION AGAINST MYCOBACTERIUM TUBERCULOSIS CENTER (IMPAC-TB)

The goal of this program is to establish an integrated multi-disciplinary team of highly collaborative investigators that will plan and conduct iterative, in-depth immunologic analyses of tissue-specific and systemic responses in small animals, non-human primates (NHPs), and humans to identify the key immune responses needed for protection against Mtb and to identify immunologic targets that can be used to improve TB vaccine strategies. This study will assess whether co-infection with SARS-CoV2 has a significant impact on innate immunity in study participants spanning the Mycobacterium tuberculosis (Mtb) infection spectrum.